Harmonizing Variable Level Information from the NIA Funded Longitudinal Studies on Aging to Create Cross-study CDE's for Alzheimer's Disease and Alzheimer's Disease Related Dementias (AD/ADRD)

ABSTRACT
This supplement application identifies and organizes health questions and measures of Alzheimer's Disease
and Alzheimer's Disease Related Dementias (AD/ADRD) and other cognitive impairments using longitudinal
studies supported by the National Institute on Aging (NIA). Specifically, the supplement targets high impact
studies identified as “Tier 1” studies in the NIA 2016 Data Infrastructure Review. The National Archive of
Computerized Data on Aging (NACDA) mission is to create a dynamic and flexible data infrastructure to
stimulate health research and advance knowledge related to the gerontological lifecourse. This supplement
application builds upon our work “Creating an Interoperability Data Infrastructure for Research on the Aging
Lifecourse” funded by NIA (R21AG073358-01). This research grant seeks to accomplish three critical goals
central to the work of the proposed supplement 1) Identify- core elements of aging data need to be formally
cataloged and structured at the metadata level. This process includes variable-level information and concepts
using a "Common Data Elements" (CDE) approach; 2) Integrate- relate independent longitudinal studies to
each other across health thematics, establishing an XMI/DDI template to allow cross-study analysis using DDI
Lifecycle markup; Operationalize- make the data resources available to the research community, provide
ongoing support, and training for the interoperability portal. The project will provide training and educational
services through conference presentations, workshops, and online webinars. The proposed supplement will
address these goals by identifying variables measuring AD/ADRD and other cognitive impairments within Tier
1 studies as well as sociodemographic, and comorbidity data commonly associated with increased risk of
AD/ADRD.

Public health relevance
PROJECT NARRATIVE NACDA promotes a better understanding of health and the promotion of health behaviors by collecting data and research information on the aging lifecourse. This information is reprocessed and then distributed from the NACDA website, providing a large and growing set of research tools to facilitate the study of disease, aging and overall health. This project will facilitate multidisciplinary research using longitudinal data focused on cognitive functioning and Alzheimer’s research.